Precision Monitoring and Assessment in the Framingham Study: Cognitive, MRI, Genetic and Biomarker Precursors of AD & Dementia: Supplement; Framingham Heart Study Brain Aging Program (FHS-BAP)

PLEASE SEE SUPPLEMENT RESEARCH STRATEGY

Public health relevance
ORIGINAL OVERALL NARRATIVE The financial and societal cost of caring for 5.7 million people in the U.S. with Alzheimer disease (AD) is staggering and the suffering to those afflicted by AD and their families is incalculable. We expect that the Framingham Heart Study Brain Aging Program will improve our understanding of the roles of vascular and inflammatory factors in AD, identify new biomarkers for early diagnosis and prediction of disease course, determine circumstances that may lead to disease prevention and suggest potential novel therapeutic targets.